EVALUATION OF IVIG AND ZIDOVUDINE IN CHILDREN WITH SYMPTOMATIC HIV INFECTION

This protocol evaluates the safety, tolerance, and efficacy of ZDV plus IVIG versus ZDV plus placebo in children with symptomatic HIV infection, excluding children with LIP alone.